Development of brain-scale neural circuits underlying vertebrate visuomotor transformations

ABSTRACT
It remains considerably challenging to restore vision after developmental disturbances, such as congenital
infantile nystagmus, and after injury or retinal degeneration. This is because the mechanisms establishing
functional connectivity between retinal ganglion cells and their downstream targets in the brain remain poorly
understood. This knowledge gap is partly because observing the functional emergence, stabilization, and
maintenance of entire visual neural circuits is impossible in mammals. This project will leverage the strategic
experimental advantages of the larval zebrafish, a vertebrate model system, to investigate the functional
maturation of a conserved neural circuit underlying a visual orienting behavior, the optomotor response (OMR).
This will form the basis for understanding how congenital disorders exert their effects and how new neurons
added after initial circuit development can support healthy visual processing. Recently, we described the
transformation of retinal visual motion signals into motor output and showed that it required many different types
of neurons distributed across the brain. These neurons can be classified based on their diverse eye- and
direction-specific response profiles, and they collaborate to compute how exactly visual scenes are moving.
Fascinatingly, this collaboration supports stable behavior 5 days after fertilization, even though new neurons are
added to the circuit throughout life. We will test the central hypothesis that after initial formation, the OMR circuit
expands by adding new neurons in balanced response classes, permitting the continued execution of motion-
guided behaviors. In Aim 1, we will test how the development of the behavioral repertoire and associated neural
circuitry is affected by specific disruption of direction-selective retinal input. By training recurrent neural networks,
we will generate predictive models of connectivity between direction-selective retinal ganglion cells and
downstream targets. In Aim 2, we will investigate how the functional neural representations mature, and we will
quantify the stability of individual neuronal responses over time. By computationally tracking all neurons, we will
directly investigate the trajectory of new neuron functional integration into existing circuitry and determine how
the balance of functional profiles varies over time and covaries with behavior. In Aim 3, will use holographic
photostimulation to examine the role of activity in shaping ultimate circuit role for individual neurons. Together,
these experiments will reveal how an entire motion-sensitive vertebrate circuit is functionally assembled,
providing insight about the functional connectivity between retinal ganglion cells and their downstream partners
and about the nature and utility of neurogenesis. These results will inform regenerative treatment strategies for
developmental disorders or injuries to central visual processing areas.

Public health relevance
PROJECT NARRATIVE It remains considerably challenging to restore vision after retinal degeneration and developmental disturbances, including infantile nystagmus, as the mechanisms underlying functional connectivity between retinal ganglion cells and their downstream targets remain poorly understood. This project investigates how direction-selective retinal ganglion cells drive motion-sensitive neurons across the zebrafish brain over development to elicit the visually guided optomotor response. health and disease Insights into how entire visuomotor neural circuits assemble and function in are likely to be of critical importance for the development of regenerative treatment strategies.